Center for Health Innovation and Maximizing Elder Care

Project Summary Overall Component
UCLA Center for Health Improvement for Minority Elders (CHIME) proposes continuation of a research and
mentoring program continuously funded in 2002, that will contribute to the reduction in health disparities for
minority elders by training minority faculty who will advance their careers by conducting minority aging
research. We propose to continue our theme of “Developing, Adapting and Evaluating Interventions to
Improve the Health of Minority Elders”, which incorporates elements of two of RFA-AG-23-026 research
objectives: i) identify and develop solutions to eliminate health disparities and health inequities in the growing
population of older adults, and ii) improve the health and well-being of older adults. CHIME has 6 specific aims:
1) to develop the research infrastructure needed to improve the health of minority elders through the
development, implementation, and evaluation of community and health system interventions designed to
mitigate health disparities which incorporates two of NIA's areas of scientific focus: identify and develop
solutions to eliminate health disparities and health inequities in the growing population of older adults, and
improve the health and well-being of older adults; 2) to conduct rigorous analyses of existing data sets to
identify sociocultural factors, health care factors, and behavioral and biological level correlates of health
disparities to inform the design of interventions or health policies to mitigate health disparities; 3) to contribute
to the development, evaluation, and dissemination of measures that can be used to track health outcomes or
measure critical social, behavioral, and economic predictors of the health and the health-care of minority
elders; 4) to build on CHIME’s 20-year track record of successful academic advancement of minority faculty
through mentorship and support of their conduct of independent research on the health of minority elders; 5) to
broaden both existing and new partnerships with communities to expand the pool of potential minority research
participants and the beneficiaries of the findings from both the research conducted under the auspices of
CHIME and other funded research. 6) Continue our long-standing and highly successful partnership and
collaboration with Charles R. Drew University of Medicine and Science (CDU), a HBCU, while also developing
an additional partnership and collaboration with the University of California at Riverside (UCR), a Hispanic
Serving Institution (HSI) with expertise in training Hispanic students and those from other under-represented
groups. CHIME will address these aims through activities that are organized in a Leadership and
Administration Core (LAC), a Research Education Component (REC), an Analysis Core (AnC), and a
Community Liaison and Recruitment Core (CLRC). The LAC and REC in collaboration with the External
Advisory Group will select pilot studies and organize the mentorship and development of RCMAR Scientists,
CLRC will assist with recruitment and AnC will provide highly innovative methodological training for RCMAR
Scientists.

Public health relevance
Project Narrative UCLA Center for Health Innovation and Maximizing Eldercare (CHIME) proposes continuation of a research and mentoring program continuously funded in 2002, that will contribute to the improvement of health outcomes for older adults by training early stage faculty who will advance their careers by conducting aging research.